MITOCHONDRIAL PROTEIN IMPORT IN AFRICAN TRYPANOSOMES

DESCRIPTION (Adapted from applicant's abstract) Blood borne parasitic disease are major causes of human morbidity and mortality, particularly in the tropical world. African trypanosomes, the protozoa of the Trypanosoma brucei complex, are such parasites that live extracellularly in the blood and tissue fluids of the vertebrate host, utilizing blood glucose as their sole source of energy eventually leading to hypoglycemia and disease syndrome known as African sleeping sickness. Mitochondrial biogenesis is an essential part of the digenetic life cycle of this protozoa. These cells suppress their mitochondrial activities when they live in the bloodstream of its mammalian host. During bloodmeal, parasites are transferred to the insect gut and there they regenerate their mitochondrial activities. Import of a vast majority of nuclear encoded mitochondrial protein is a necessary process for mitochondrial biogenesis. The goal of this study is to characterize mitochondrial protein import mechanisms in African trypanosomes so as to understand their roles in mitochondrial biogenesis. The initial requirement to accomplish this goal is the isolation and characterization of the trypanosome proteins involved in mitochondrial protein import. The specific aims of this proposal are: 1) to identify and characterize the receptors that import proteins across the outer mitochondrial membrane from T. Brucei; and to assess whether they are differentially expressed during the parasite life cycle; 2) to clone and characterize components of the TOM complex (TOM70, TOM40, TOM22, and TOM20) from T. Brucei; and 3) to study the roles of these cloned proteins in the import of the recombinant trypanosome alternative oxidase protein into isolated mitochondria of T. brucei. Characterization of the mitochondrial import machinery in this parasite may provide insight into genetic control mechanisms in trypanosomes where, in contrast to most eukaryotes, developmental regulation of gene expression is almost entirely post-transcriptional. Understanding of this developmental process will elucidate one of the major aspects of trypanosomal parasitism. This in turn will help us to design rational trypanocidal chemotherapeutic strategies.